VITAMIN INTERVENTION FOR STROKE PREVENTION (VISP)

This study is designed to determine whether folic acid, vitamin B6 and vitamin B12 will prevent recurrent stroke by reducing levels of homocysteine in patients suffering a stroke. The effect of homocysteine reduction on reduced risk for myocardial infarction and fatal coronary heart disease will also be looked at.